4/7 Clozapine for the Prevention of Violence in Schizophrenia: a Randomized Clinical Trial

PROJECT SUMMARY
While most people with psychosis are not dangerous and most violence is committed by non-psychotic people,
people with psychotic disorders are at increased risk for violence, and violence is associated with worse
outcomes and increased stigma. Therefore, decreasing violence risk in psychosis is clinically relevant and has
important public health implications. Several clinical studies suggest that clozapine is superior to other
antipsychotic medications in reducing violence or aggression. However, there were numerous limitations of
these studies including that most of them were observational and non-randomized, included small sample sizes,
or focused on hostility, non-physical aggression, or self-harm, rather than violent acts. Further, the majority of
these trials were not generalizable to outpatient, community settings. No large effectiveness study has
examined the effects of clozapine on violent behavior in community settings. We propose a randomized,
parallel-group, 24-week, open-label, single (rater)-blind, 7-site clinical trial to examine the effects of treatment
with clozapine vs. treatment as usual (TAU) on the risk of violent acts in 280 individuals with schizophrenia at
high risk for violence. This trial will be a collaboration of 7 sites, coordinated by the New York State Psychiatric
Institute. The 6 additional collaborating sites contribute unique expertise and will ensure an adequate sample
size for this trial. Our primary effectiveness outcome is time to violent acts as measured by the MacArthur
Community Violence Interview (MCVI). We will also explore the effects of clozapine on the Point Subtraction
Aggression Paradigm. While many factors may contribute to violent behavior in individuals with schizophrenia,
including positive symptoms, psychopathy, impulsivity, and substance use, evidence suggests that the final
common pathway for many of these disparate causal influences likely runs through behaviors captured by the
Excitement Factor of the Positive and Negative Syndrome Scale (i.e., a composite of the scores of excitement,
uncooperativeness, poor impulse control, and hostility). Importantly, our target (the excitement factor of the
PANSS) has been validated to measure excitement-like symptoms in clinical trials in schizophrenia, is sensitive
to treatment, has been linked to the neurobiology of violence in MRI and PET studies, and differentiates
clozapine from other antipsychotic drugs. We will also explore the effects of clozapine vs. TAU on positive
symptoms (e.g., persecutory delusions) and alcohol and substance use, and how these effects influence the
risk for violent acts. To enhance the safe implementation of this study in this vulnerable population at risk of
violent behaviors, we will implement clinical safety and treatment engagement protocols that rely upon standard
personnel and that will be readily generalizable. This trial will provide guidance on the use of clozapine for
violence in community settings and will definitively test hypotheses regarding mechanisms of its anti-violence
effects. The results will be immediately relevant to practice and will impact public health because there is
currently no standard approach for the treatment of violence in schizophrenia.

Public health relevance
PROJECT NARRATIVE The development of strategies and interventions for preventing or minimizing violent behavior in individuals with psychotic disorders has been limited, in part, by a lack of information about the effects of antipsychotic medications, and in particular clozapine, on violent acts in community settings. In this project, we will determine whether clozapine, when administered in real-world settings, decreases the risk for violent acts in individuals with schizophrenia at high risk for violence when compared to treatment with other antipsychotic medications, and investigate whether previously identified change mechanisms are operative in the effectiveness setting. Examining clozapine in this way will foster a better understanding of the effects of clozapine on violent acts in community settings and allow us to test a scalable intervention and service delivery approaches that can be broadly implemented using typically available resources, and as such has significant public health implications.